Improving Symptom Management for Survivors of Young Adult Cancer

More than 60,000 young adults (YAs) aged 18-39 are diagnosed with cancer in the US each year. Advances in
treatment have yielded five year survival rates >70% suggesting that the majority of YAs will become long-term
cancer survivors. Symptom (e.g., pain, fatigue, distress) interference is common for YA cancer survivors and
impacts their abilities to achieve normative life goals (e.g., returning to work/school, achieving autonomy,
pursuing social/romantic relationships) and adhere to recommended follow-up care. Symptom management has
been identified as a significant issue in the transition to survivorship for YAs by the Institute of Medicine and
National Cancer Institute, and assistance with symptom management is rated as an important and unmet need
by YA survivors. Yet, behavioral symptom management interventions have not targeted the needs of those
diagnosed as YAs. The proposed study aims to develop and test the feasibility and acceptability of a novel
behavioral symptom management intervention designed for survivors of YA cancer (cancer types: hematologic,
breast, or gastrointestinal cancers, melanoma, or germ cell tumors). The hybrid intervention will include in-
person, group sessions and an integrated mobile application. The intervention will provide peer support while
also teaching skills to improve symptoms, symptom interference, and self-efficacy for symptom management.
The mobile application will assist with symptom monitoring, home skills practice, and connecting with group
members. The preliminary version of the intervention will be guided by the research team’s prior work developing
and testing symptom management interventions for cancer survivors, national guidelines for YA oncology,
consultation with an expert advisory board, and input from patient (3 groups, n=10/group) and provider (1 group,
N=10) stakeholders obtained during focus groups. The intervention will be further refined following review by
patient user testers (n=10). Next, feasibility, acceptability, and distributions of change over time as well as
relationships between outcome variables will be examined through a pilot randomized clinical trial of the
developed intervention. Participants (N=60) will be randomized to intervention or wait-list control arms. Primary
study outcomes are symptom (pain, fatigue, distress) severity and symptom interference. Self-efficacy and
support will also be examined as mediators of change in outcome variables. The proposed study has the potential
to make several significant contributions by targeting an underserved group of cancer survivors, addressing a
critical gap in care, and addressing variables consistently linked to social, economic, and health burden for YAs.
It will also provide important information about approaches to identify, recruit, and retain YA cancer survivors in
research and provide pilot data for a larger trial. Formal training in the following areas will strengthen the PI’s
ability to become an independent investigator developing, evaluating, and disseminating interventions for YA
cancer survivors: 1) clinical trial design and statistical methods, 2) use of mHealth technology for research and
intervention delivery, 3) needs of cancer survivors diagnosed as YAs, and 4) professional development.

Public health relevance
Project Narrative Symptom interference is common for survivors of young adult cancer (aged 18-39 at diagnosis) and impacts their abilities to achieve normative life goals (e.g., education, careers, independence, romantic/social relationships) as well as adhere to recommended follow-up care. Assistance with symptom management has been rated by young adult survivors as an important and unmet healthcare need; however, skill-based symptom management interventions have typically been tested among older cancer survivors and have not targeted the unique developmental needs of those diagnosed as young adults. The proposed research advances the health and wellbeing of young adult cancer survivors by creating a developmentally appropriate hybrid in- person/mHealth behavioral symptom management intervention which addresses variables (i.e., symptoms and symptom interference) consistently linked to significant social, economic, and health burden.